Continuation of the Cooperative Agreement between U.S. FDA and SCDHEC to advance conformance with Voluntary National Retail Food Regulatory Program Standards.

Getting awarded the Advancing Conformance with the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) Cooperative Agreement will allow the South Carolina Department of Health and Environmental Control (SCDHEC) to continue to: 1. Provide resources to program areas where the greatest impact on retail food safety is being made; 2. Continue to implement risk factor intervention strategies while looking for methods to reach wider audience/application/use; 3. Identify program areas which are nearing conformance with a Standard, and make efforts to be ready for a validation audit; 4. Maintain the Standards that we have already met, and bring them back into conformance as FDA Food Code (Food Code) updates are made; 5. Continue to find new ways to improve program efficacy and best use of program resources; and 6. Establish and maintain good relationships with both consumers and industry personnel. This can be accomplished through uniform inspections with a “partnership” approach. In July 2017, a full-time VNRFRPS coordinator was hired to manage the activities and responsibilities related to the Retail Food Standards program. Since hiring the VNRFRPS coordinator, Standards’ criteria have been held to the appropriate, stringent requirements of the Food Code and other guidance. A new VNRFRPS coordinator was hired in December 2019, to continue the progress made by the previous coordinator who resigned from the position in August 2019. The previous coordinator remains a member of the DHEC staff which allows frequent communication between both employees to ensure a seamless transition for the Retail Food Standards program. Upon review of the SCDHEC Strategic Action plan, it can be seen that conformance percentages temporarily declined for several of the retail standards in the August 31, 2017, VNRFRPS review. This was because assessments performed prior to the hiring of a full-time coordinator were of lower quality than the assessments we conduct today with a full-time coordinator. Self-assessments and reviews done by the VNRFRPS coordinator will be more extensive, exhaustive, and critical than those conducted prior to July 2017, to ensure accurate conformance reporting. The VNRFRPS coordinator will continue to be responsible for satisfying all requirements of this Cooperative Agreement, such as: 1. Completing the Mid-Year and Final Progress Reports in a timely fashion; 2. Updating status reports on the hiring and training of food program personnel; 3. Acquiring updated funding certifications and corresponding with SCDHEC Bureau of Finance in regard to VNRFRPS needs; and 4. Developing and maintaining a strategic plan that accurately reflects when specific objectives and tasks have been, or will be, completed and/or implemented and when new objectives and tasks are identified to advance conformance with the Retail Program Standards.

Public health relevance
The South Carolina Department of Health and Environmental Control (SCDHEC) has made great strides since the hiring of a full-time employee to advance conformance with the Standards. SCDHEC has achieved full conformance and has been audited for that full conformance with Standards 1, 3 and 7. Standard 2 is self- assessed to be at 100% conformance and will soon be ready for audit. It is also anticipated that 100% conformance with Standard 6 will be possible upon the completion of SCDHEC’s next effectiveness assessment. Standard 4 and Standard 9 have increased to 92.30% and 71.40% respectively. Work is still required to achieve full conformance with these Standards, as well as Standards 5 and 8. It goes without saying that the Department’s VNRPRPS program has made significant progress thanks to the resources provided by the Cooperative Agreement. The following table illustrates the progress made in each Standard from the hiring of the Retail Food Standards coordinator to the most recent assessment of conformance: Conformance Percentages as of 8/31/2017 (FTE is Hired) Conformance Percentages as of 3/16/2018 Conformance Percentages as of 12/31/2018 Conformance Percentages as of 08/15/2019 Date of Conformance Based on Verification Audit 0.00% 71.40% 71.40% 100.00% 9/25/2019 0.00% 77.80% 100.00% 100.00% - 100.00% 100.00% 100.00% 100.00% 4/12/2018 68.80% 38.50% 92.30% 92.30% - 48.30% 55.20% 55.20% 58.62% - 50.00% 75.00% 75.00% 75.00% - 100.00% 100.00% 100.00% 100.00% 4/2/2018 23.10% 38.40% 46.20% 61.50% - 28.60% 28.60% 28.60% 71.40% - These results would not have been possible without the VNRFRPS Cooperative Agreement. The continuation of this program funding will allow SCDHEC to proceed with its goal of fully meeting the Standards while ensuring South Carolina’s public enjoys the maximum possible retail food safety. The VNRFRPS program actively monitors and assesses SCDHEC’s food program as a whole, and by conforming with more Standards over time, it helps enhance protection for the residents of South Carolina against foodborne outbreaks. The full listing of the current conformance percentages for each of the Standards can be found on SCDHEC’s Strategic Plan document which will be included with this funding application.